Annual Conference: American Society of Preventive Oncology

[unreadable] DESCRIPTION (provided by applicant): The primary purposes of the American Society of Preventive Oncology (ASPO) are the exchange of information and the promotion of research in cancer prevention and control. This application requests partial support for the 2008 through 2011 annual meetings of this multidisciplinary organization. In order for ASPO to provide a high quality program and to continue to grow and provide new opportunities for junior investigators, some level of outside support is necessary. In recognition of ASPO's limited resources and increasing costs for annual meetings, no honoraria are offered, but expenses of invited speakers are covered. [unreadable] [unreadable] ASPO annual meetings are organized to consist of four to six symposia, submitted paper sessions, award lectures, interest group breakfast sessions, and a poster session scheduled over two days. Pre-meeting workshops consist of a new investigators workshop, a professional development session, a meeting of the cancer center Associate Directors for Cancer Control and Prevention, and meetings for NIH trainees and NCI training grant directors. Breakfasts will be reserved for late-breaking topics of interest to the ASPO membership. Several months prior to each annual meeting, abstracts are solicited for oral and poster presentation. The 16 abstracts receiving the highest rankings will be published in the peer-reviewed journal, Cancer Epidemiology, Biomarkers & Prevention. The 18 top-ranked abstracts in various categories will be presented orally during paper sessions. Based on past experience, it is anticipated that approximately 90-100 posters will be presented during the poster session. An award will be given for the best poster. Journal advertisements, posters and direct mail will be used to publicize the meeting. [unreadable] [unreadable] The 32nd annual meeting will be in Bethesda, Maryland, March 16-18, 2008 at the Hyatt Regency Hotel. Over 300 participants are anticipated to attend future annual meetings. Speakers and participants are from diverse disciplines involved in cancer prevention research and, most significantly, from disciplines concerned with translating known information into effective prevention programs. All meetings will be held in non-smoking fully-accessible conference facilities. By fostering communication among professionals in several disciplines of cancer prevention, ASPO meetings provide an intimate atmosphere that supports mentoring, encourages dialogue, and promotes innovative progress in cancer control. [unreadable] [unreadable] [unreadable]